Designing a mobile intervention for dysregulated eating and weight gain prevention in adolescents

PROJECT SUMMARY/ABSTRACT
Pediatric overweight and obesity continue to be major public health issues. Loss of control (LOC) eating and
overeating are two obesity-related phenotypes affecting ~30% of adolescents with overweight/obesity that may
undermine weight control treatment outcome. There are very few empirically-supported interventions targeting
these behaviors to promote weight regulation in adolescents. Cognitive-behavioral therapy (CBT) has
promising effects on dysregulated eating, but effects on weight are often modest. Importantly, CBT fails to
adequately address developmental changes in self-regulation, which may limit CBT skill utilization in the
moments and contexts in which they are needed most. Moreover, CBT is costly, time intensive, and
inaccessible to most teens. Digital interventions overcome many of these barriers and hence may be an
optimal format for achieving engagement and scale, especially given the ubiquity of technology usage in
adolescents. Our group has tested the only digital CBT interventions targeting dysregulated eating and weight
in adolescents with overweight/obesity, and while effects on weight and LOC eating were promising, improved
design and updated delivery modes (i.e., Smartphone) are needed to strengthen engagement and clinical
outcomes. To achieve optimal engagement and efficacy, such interventions should be built around
developmentally appropriate theoretical models and informed by user needs and preferences. In the current
proposal, we will apply user-centered design methods to design and test a novel CBT-based digital
intervention, augmented with content and features to improve self-regulation, for weight gain prevention and
dysregulated eating in adolescents. The intervention will address behavioral, physiological, affective, and
environmental processes that impact eating and weight control, informed by self-regulation theories, and will
be guided by formative design work to ensure that content and features meet the needs of adolescents for
whom it is intended. The first phase will involve design activities with adolescents who have or are at risk for
overweight/obesity and report dysregulated eating, to understand desired packaging/presentation, features,
and barriers/facilitators to engagement. Research activities will include a needs assessment and iterative
prototyping, usability testing, and refinement of the digital intervention. The second phase will be a multisite
single arm open trial involving 50 adolescents who have or are at risk for overweight/obesity and report LOC
and/or overeating to investigate intervention feasibility and preliminary efficacy, as well as putative treatment
mechanisms and targets. Results of the study will directly inform design of a larger, adequately-powered
randomized controlled trial and will help advance scientific and clinical understanding of optimal treatment
strategies for adolescents with eating- and weight-related problems. Further, the project has clear potential to
significantly impact public health via development of a relevant, accessible, and scalable intervention for
adolescents at high risk for adult obesity and eating disorders, and related adverse health conditions.

Public health relevance
PROJECT NARRATIVE Efficacious interventions for adolescent loss of control eating and overeating are urgently needed given their adverse impacts on weight outcomes and psychosocial functioning. Existing interventions, while promising, fail to comprehensively address self-regulation factors that may impede optimal adherence/behavior change, have modest effects on weight, and can be costly, time/resource intensive, and inaccessible to many adolescents in need. The aim of this small R01 is to design and pilot test a novel technology-based, user-informed, and potentially scalable cognitive-behavioral intervention for adolescents with or at risk for overweight or obesity, built around evidence-based self-regulation theories of maladaptive eating, which has potential to alleviate public health burdens incurred by eating- and weight-related problems.